A novel regulator of antiviral innate immune response in cardiomyocytes

Summary
Innate immunity is increasingly recognized as a critical contributor to multiple cardiac pathological
conditions. A better understanding of cardiomyocyte-autonomous innate immune response is
crucial for developing more effective treatments for these conditions. Junctophilin-2 (JPH2), a
protein essential for heart health, is traditionally believed to primarily responsible for facilitating
Ca2+ induced Ca2+ release (CICR) within cardiomyocytes. However, our recent findings have
revealed a novel function of JPH2 as a double-stranded RNA (dsRNA)-binding protein that
sequesters dsRNA, thereby suppressing dsRNA-induced innate immune responses in
cardiomyocytes. This newly identified function challenges traditional views of JPH2 in cardiac
pathology, and suggests that self-RNA immunogenicity may play a previously unrecognized role
in JPH2 deficiency induced heart failure. Additionally, our preliminary data indicate that dsRNA
binding may induce structural changes in JPH2, potentially impacting JPH2’s role in CICR. This
project seeks to address two key questions: (1) to what extent does self-RNA immunogenicity
contribute to heart failure in the context of JPH2 deficiency, and (2) whether dsRNA binding
induces JPH2 structural changes that alter its role in CICR. In Aim 1, we will determine the
contribution of self-RNA immunogenicity and dsRNA-activated PKR to JPH2 KO-induced heart
failure by using a CRISPR-mediated double-knockout mouse model and a synthetic dsRNA-
sequestering protein. Aim 2 will address the structural changes in JPH2 upon dsRNA binding
using Electron Paramagnetic Resonance, and assess the impact of cytosolic dsRNA on CICR
machinery. This research is anticipated to redefine JPH2’s roles in cardiac biology, revealing new
mechanisms of cardiac pathology and identifying potential therapeutic targets for cardiomyopathy.
In addition, it will create novel mouse models and synthetic biology tools.

Public health relevance
Project Narrative The cell-autonomous innate immune response is pivotal in the development of various cardiac diseases, highlighting the urgency of identifying cardiac-specific regulatory mechanisms. This research will define the novel roles of JPH2 protein in regulating innate immune response of cardiomyocytes, and its consequential impact on heart failure. The outcomes are expected to provide new mechanistic insights and potential therapeutic avenues for cardiac diseases.